Pathogenesis of staphylococcal biofilm-related infection

In FY 2014, we continued our efforts to understand the impact that phenol-soluble modulins have on biofilm development. We have completed our set of isogenic deletion mutants in S. epidermidis psm loci to investigate the role all PSMs play in S. epidermidis biofilm development and dissemination from device-related infection in vivo and are starting investigating the impact of all PSMs on S. epidermidis biofilm formation. Furthermore, we collaborated with Dr. Hickok (Jefferson University) on characterizing biofilm formation as a phenomenon underlying difficult-to-treat joint infections. This project has been extremely successful, resulting in a series of collaborative publications on the pathogenesis of staphylococcal joint infection.